Examining Carbon Monoxide to Treat Inflammatory Conditions using Experimental Colitis Models

Abstract
Carbon monoxide (CO) is an endogenous signaling molecule with importance on par with nitric oxide (NO), the
subject of the 1998 Nobel Prize. It is produced from heme degradation by heme oxygenases. Extensive
literature reports have convincingly demonstrated the therapeutic effects of CO as an anti-inflammatory agent
in models of colitis, sepsis, liver injury, and organ transplant. While much is known regarding the efficacy of
CO, the challenge now is to develop pharmaceutically acceptable deliverable forms of CO as research tools
and possible therapeutics. Inhaled CO has been the major form of delivery in most preclinical work. However,
this is not the ideal modality because of difficulties in safe administration and in controlling doses, lack of
portability, and the dependence on each individual patient’s respiratory function to deliver precise amounts.
There have also been a number of metal-based CO-releasing molecules (CO-RMs) and photo-sensitive
organic CO-RMs. However, metal toxicity and light accessibility issues impose limitations. In an exciting
development, we have developed several classes of organic CO-prodrugs with tunable release rates. We
propose to explore the potential of using such prodrugs to treat inflammation and tissue injury using
experimental colitis (EC) in mice as a model. Others and we have demonstrated the unique ability of CO to
reduce inflammation, promote tissue repair, and enhance host defense against pathogenic bacterial infection.
Therefore, CO has enormous potential to be an effective treatment for colitis without the increased risk of
infection associated with broad immunosuppression. With the high cost of drug discovery and development
which is way beyond the funds available in an NIH application, we plan to initially examine a well-defined set of
issues. The availability of prodrugs with tunable release rates offers the opportunity for the first time to examine
the interplay among dosage, efficacy, pharmacokinetics, and release profiles, which is a unique problem with a
gasotranmistter. In this MPI application, we combine the extensive expertise of the Wang, Tan, and Otterbein
labs, and propose to build on compelling preliminary data to develop organic CO-prodrugs for treating
inflammation in EC models. Our central hypothesis is that CO-prodrugs acts therapeutically in EC by
modulating the intestinal microenvironment. We will test this with the following 2 specific aims: 1.) synthesize,
optimize, and assess CO prodrugs; and 2.) evaluate the CO-prodrugs in EC. Our preliminary results clearly
show efficacy of such CO-prodrugs in treating murine EC, sepsis, and liver injury. Upon completion of the
project, we expect to have: 1.) developed a series of CO prodrugs, 2.) demonstrated the feasibility of using
such prodrugs to treat inflammation in EC models; and (3) defined the relationship among dose, release
kinetics, pharmacokinetics and efficacy with a clear therapeutic window. The clinical potential of CO-based
therapeutics as anti-inflammatory agents is profound and could impact other areas such as organ
transplantation, stroke, and heart attack.

Public health relevance
NARRATIVE Carbon monoxide (CO) is an endogenous signaling molecule in mammals produced during heme breakdown by heme oxygenases. Numerous reports have convincingly demonstrated the therapeutic effects of CO as an anti-inflammatory agent in models of colitis, sepsis, ischemia/reperfusion injury, and organ transplant. In this study, we aim to develop pharmaceutically acceptable forms of CO with the aim of examining key factors for the future development of new treatment options for inflammatory conditions using experimental colitis models.